Development of a highly sensitive and specific POCT testing asthma triggering allergic IgE

Summary of Administrative Supplement
The overall goal of the parent project is to develop and eventually commercialize a novel point-of-care test
capable of rapidly and highly accurately detecting allergic IgE to environmental allergens as an approach to
promote healthy living and reduce minority health disparities. This administrative supplement application is
intended to enhance the diversity of the research and entrepreneurial workforce by supporting a candidate,
Christian Lapitan, to establish a standardized procedure to ensure the consistent product quality of the reverse
lateral flow immunoassay (R-LFIA) rapid test device. The research project of this administrative supplement
for the candidate is to express, purify, characterize, and employ the recombinant allergens derived from
bacteria (E. coli) to replace the crude allergen extracts as an allergen source for preparation of allergen-gold
nanoparticle conjugates to achieve consistent and accurate test results with R-LFIA. Enhancement of research
and entrepreneurial capability for the candidate is another major purpose of this diversity supplement. To do
so, the applicant company Allerdia has developed a mentoring plan; a plan for mentor-candidate interactions;
and a plan for business and entrepreneurship enhancement.

Public health relevance
Narrative The burden of asthma in the US falls disproportionately on Black, Hispanic and American Indian/Native Alaskans/Asians, as these minority groups have the highest asthma rates, deaths and hospitalizations. Among 25 million American asthmatics, IgE-mediated allergic asthma is the major type that impacts ~75% of all the asthmatics. The most relevant allergens triggering IgE-mediated allergic asthma are environmental allergens. However, all the currently available centralized IgE tests have the common problem of high false positivity that greatly impacts the underserved minorities, leading to the health disparities. Therefore, a more accurate, convenient, low-cost, rapid and point-of-care enabled IgE test capable of rapidly and accurately identifying allergic IgE by overcoming false positivity of the current IgE tests would be a key component in efforts to enhance healthy living and reduce minority health disparities. Under such background the proposal of developing a novel IgE testing approach capable of rapidly and accurately detecting allergic IgE with point-of-care test capacity to address the health disparity issue using Allerdia’s proprietary Reverse Lateral Flow ImmunoAssay technology platform is of high clinical significance.